Integrative Multi-Omics Approach to Identify Cell-Type and Brain-Region Specific Genetic Drivers of Alcohol Use Disorder

Alcohol use disorder (AUD) is a complex condition influenced by both genetic
and environmental factors, significantly affecting millions worldwide. This project aims to
elucidate the genetic and regulatory mechanisms underlying AUD in several brain
regions previously implicated in alcohol consumption and addiction, namely, the
caudate nucleus, extended amygdala, anterio-lateral hypothalamus, and middle
temporal gyrus. Utilizing advanced single-cell multi-omics techniques, we will identify
cell-type-specific gene expression and chromatin accessibility differences in these brain
regions between individuals with and without AUD.
Specific Aim 1 will involve performing differential expression and chromatin
accessibility analyses using single-nucleus RNA-seq and ATAC-seq data. We will
identify cis-regulatory mechanisms driving these differences by integrating expression
quantitative trait loci (eQTL) and genome-wide association studies (GWAS) data.
Additionally, we will infer trans-regulatory mechanisms using advanced bioinformatics
tools to identify transcription factors and regulatory proteins involved in AUD.
Specific Aim 2 will focus on identifying genes likely to significantly contribute to
development of AUD, using Mendelian randomization and elucidating their functions
through high-throughput perturbation experiments and real-world validation. We will
perform eQTL analysis to identify variants associated with gene expression in specific
cell types, followed by two-sample Mendelian randomization to determine causal
relationships. High-throughput Perturb-seq will be used to elucidate the downstream
functions of these causal genes, and we will leverage drug-target perturbation
databases to identify potential therapeutic targets for AUD.
The fellowship training plan includes developing expertise in cutting-edge
genomics and bioinformatics techniques, gaining hands-on experience with
experimental methods such as Perturb-seq, and enhancing scientific communication
skills. Training will take place in Dr. Yunlong Liu's lab at Indiana University School of
Medicine, providing access to state-of-the-art facilities and a collaborative research
environment. This comprehensive training will prepare me for a successful career as an
independent researcher in genomics and neurobiology, contributing to the development
of targeted treatments for AUD and advancing public health.

Public health relevance
This research aims to uncover the genetic factors and regulatory mechanisms that contribute to alcohol use disorder (AUD), a condition that affects millions of people globally. By employing a broad array of genomics and computational biology methods, this study seeks to identify the specific genes and pathways involved in AUD. The outcomes of this research will provide critical insights into the biological underpinnings of AUD, facilitating the development of targeted treatments to mitigate its impact, and ultimately improve public health outcomes and enhance the quality of life for those affected by this disorder.